Suppression of AVIC inflammosteogenesis for prevention of CAVD progression

Project Summary
Calcific aortic valve disease (CAVD) is common in the elderly. CAVD progression to significant aortic stenosis
occurs over years in most patients. This indolent course affords the opportunity for therapeutic intervention to
halt the disease progression at an early stage. However, limited knowledge of mechanisms underlying CAVD
progression impedes the development of effective pharmacological therapies. In the current funding period, our
extensive studies have identified signaling mechanisms mediated by innate immune receptors, particularly TLR2
and TLR4, as regulators of the fibrogenic and osteogenic activities in human aortic valve interstitial cells (AVICs).
We also discovered that oxidized low-density lipoprotein (oxLDL) and extracellular matrix (ECM) protein matrilin
2 function as damage-associated molecular patterns (DAMPs) in human AVICs, prompting differential cell
activation with elevated fibrogenic and osteogenic activities. In addition we observed that human monocytes
activated by TLR2 up-regulate AVIC expression of pro-fibrogenic and pro-osteogenic mediators via a paracrine
mechanism. Planned studies in this renewal application will test the central hypothesis that distinct molecular
mechanisms triggered by AVIC innate immune response elevate cellular and valvular fibrogenic and osteogenic
activities through induction of cell activation and/or myofibroblastic transition. We further hypothesize that down-
regulation of AVIC innate immune response has therapeutic potential to suppress valvular fibrosis and
calcification. These hypotheses are based on our recent observation that oxLDL elevates AVIC fibrogenic and
osteogenic activities through a myofibroblast transition-independent mechanism, whereas soluble matrilin 2
elevates these activities in human AVICs through inducing myofibroblastic transition. Moreover, we discovered
that human AVICs express anti-aging protein Klotho. This anti-aging protein is capable of modulating AVIC
innate immune response. Interestingly, Klotho levels are much lower in aortic valve tissues and AVICs from
patients with CAVD, and Klotho insufficiency exacerbates valvular fibrogenic and osteogenic activities. This grant
application will address: (1) the mechanisms underlying AVIC fibrogenic and osteogenic activities, (2) the
mechanism by which Klotho insufficiency exacerbates AVIC fibrogenic and osteogenic activities, (3) anti-
inflammatory approaches to up-regulate Klotho expression in aortic valve and (4) the therapeutic potential of
Klotho to alleviate valvular fibrosis and calcification. This proposed work will provide mechanistic insights into
the pathobiology of CAVD progression and identify therapeutic targets for pharmacological intervention to halt
CAVD progression.

Public health relevance
Project Narrative Calcific aortic valve disease is the most common cardiovascular disease in the elderly. Progressive valvular thickening due to fibrosis and calcification eventually results in heart failure. Currently, aortic valve replacement or repair is the only available therapy. The major goals of this project are to elucidate the molecular mechanisms underlying valvular fibrosis and calcification and to identify targets for pharmacological intervention toward halting the progression of calcific aortic valve disease.